Imaging Synaptic Transmission of Individual Active Zones

In the current application, we propose to characterize molecular mechanisms that
generate and control presynaptic output strength across several neuronal subtypes using
Drosophila as a model system. Synaptic vesicle fusion occurs through a highly probabilistic
process, often with only a small percent of action potentials triggering release from individual
active zones (AZs). Although AZs largely share the same complement of proteins,
release
probability (Pr) is highly variable across different neurons and between AZs of the same neuron.
Indeed, some AZ-specific proteins are non-uniformly distributed, and the molecular composition
of AZs can undergo rapid changes. To date, Ca2+ channel abundance and Ca2+ influx have
been most strongly linked to
Pr heterogeneity, though other factors are likely to contribute as
well. The Drosophila neuromuscular junction (NMJ) has emerged as a robust model system to
characterize determinants of
Pr.
We have developed tools for birth dating and serial in vivo
imaging of the same AZ population over a multi-day period beginning shortly after synapse
formation. In addition to
intravital imaging of AZ development and associated protein content,
we developed biosensors that allow quantal imaging of all SV fusion events occurring through
both spontaneous and evoked release at single AZs. We also defined the transcriptomes of
Drosophila tonic and phasic glutamatergic motoneuron subtypes that display distinct AZ
structure, Ca2+
influx and synaptic output. Using these toolkits, we propose to characterize how
Ca2+ channels traffic to and accumulate at AZs to regulate presynaptic output. In addition, we
will determine the molecular underpinnings that generate distinct synaptic structure and function
associated with two closely related glutamatergic cell types. Finally, we will determine how
alterations in neuronal activity regulate AZ development and structure. Together,
these studies
will provide new insights into presynaptic mechanisms that control synaptic communication
across several neuronal subtypes.

Public health relevance
This research will define basic mechanisms underlying neurotransmitter release and calcium channel trafficking at single active zones. Alterations in synaptic signaling are linked to multiple neurological and psychiatric diseases, while many neuromodulators and therapeutics act directly on presynaptic calcium channels. By defining how neurons regulate the trafficking and active zone dynamics of key proteins that underlie neuronal communication and mediate synaptic transmission, our research will provide a foundation for developing therapeutic approaches for brain diseases that alter synapse formation and function.